A sleep electroencephalography biomarker predicting Alzheimer's disease pathology

Project Summary/Abstract: Early biomarkers of Alzheimer's disease are urgently required for at least three reasons: (i) to determine which individuals are at greatest Alzheimer's disease risk, thereby (ii) offering preventative intervention, pre-disease onset, and (iii) further allowing nascent treatment intervention as early as possible in the disease process. All three goals demand a sensitive, non-invasive, affordable, accessible biomarker of Alzheimer's disease pathology/progression. Addressing these needs, we propose to test the hypothesis that a unique NREM sleep EEG signature provides a candidate early biomarker of Aβ pathology, one that may accurately track and forecast Alzheimer's disease risk and Alzheimer's disease pathophysiological progression. If correct, the proposal would establish a novel, inexpensive, and early diagnostic tool for determining Alzheimer's disease risk and pathology progression before clinical symptoms emerge, and one that is suitable for community settings. Moreover, such data would motivate an increased medical awareness regarding the importance of treating sleep difficulties across the lifespan, and further motivate the development (clinical or commercial) of sleep-based interventions that improve adult sleep and thus reduce Alzheimer's disease prevalence and its societal burden. More generally, such findings would argue for improved public health policies advocating for sufficient quality sleep throughout adulthood—a memorandum that may lower dementia risk and maintain cognitive health across the populous.

Public health relevance
Project Narrative: This proposal seeks to determine whether a unique NREM sleep EEG signature provides a candidate early biomarker of Aβ pathology, one that may accurately track and forecast Alzheimer's disease risk and Alzheimer's disease pathophysiological progression. The goals of the proposal are to therefore establish a novel, inexpensive, and early diagnostic tool for determining Alzheimer's disease risk and pathology progression before clinical symptoms emerge, and one that is suitable for community settings.